Project 1: Implementing Risk-based Tools that Incorporate Tumor Biology to Optimize Screening and Prevention

In 2016, we initiated the first large-scale clinical trial to personalize screening based on individual risk, which
varies significantly among women. The WISDOM Study is a multi-center, randomized comparative
effectiveness trial to determine if personalized screening recommendations based on a woman’s individual
breast cancer risk is as safe and causes fewer morbidities than the current US approach of annual screening
for all women. In the intervening time, there have been a number of important advances in breast cancer risk
assessment. In particular, there is evidence that models of risk can not only predict a woman’s risk for breast
cancer, but can predict risk for specific breast cancer subtypes.
This Project will extend the WISDOM Study for a period of five years, integrating models of risk that predict
specifically for the development of fast-growing and slow-growing cancers. Women with high-risk for fast-
growing cancers will be recommended earlier and more frequent screening with more sensitive imaging
methods. Women at high risk for slow-growing cancers will be offered endocrine risk reduction. In order to
compare the impact of this subtype-specific approach on screening outcomes, we will first acquire and
determine the subtype of cancers that arose in the original WISDOM cohort as well as the new cohort
assessed with subtype-specific models. The primary aim is to determine if the subtype-specific models indeed
enrich for the type of tumor detected (fast or slow-growing). We will see if this approach increases the
efficiency of screening (cancers/1000 women screened) compared to the reported rates from the BCSC model.
We will also compare whether the fast and slow prediction increases the fraction of fast-growing cancers that
are screen detected compared to the first cohort in WISDOM prior to subtype tumor prediction. The secondary
aims include the fraction of women at high-risk for slow growing tumors that take up risk reducing interventions
and whether those that do develop fewer cancers. As well, we will look to reduce morbidity of screening.
Project 1 will implement and help validate advanced cancer and subtype-specific risk models that integrate
family history, mammography (2D and 3D)-based artificial intelligence algorithms and refined polygenic risk
scores developed from large external cohorts. A collaboration with the leadership of the CISNET/MISCAN
model of breast cancer screening will allow us to evaluate the potential healthcare impacts of these new
subtype-specific risk models to determine whether they should be adopted as part of subtype specific risk
prediction models. The goal is to increase health care value of screening by the end of this P-01.
Extending the utility of the existing WISDOM infrastructure represents exceptional value for a ground-breaking
research program that will significantly advance our understanding of the potential for risk-based approaches
to impact breast cancer screening outcomes. WISDOM’s team is an extremely diverse, multidisciplinary and
seasoned investigator group that is passionate about improving and personalizing screening and prevention.

Public health relevance
PROJECT 1: NARRATIVE Our ongoing WISDOM clinical trial is among the first attempts to try a new approach to breast cancer screening in which each woman receives a personalized screening and prevention recommendation based on her individual risk of breast cancer. Since we began in 2016, we have learned how to better estimate a woman’s breast cancer risk and we can now begin to determine whether a woman is at risk for fast-growing cancers or slow-growing cancers. In this research project, we will investigate if more intense screening for women who are high-risk for fast-growing cancers will help detect them earlier when they are more treatable, while also offering women who are at high risk of slow-growing cancers an opportunity to begin risk-reducing therapy that has already proven to be effective for breast cancer prevention, and reduce the burden of screening for average risk.